TDP-43 dependent cryptic exons in neurodegenerative disorders: pathogenic mechanism and therapeutic strategy

PROJECT SUMMARY
Tar DNA/RNA-binding protein 43kDa (TDP-43) is an RNA binding protein mainly localized in the nucleus,
serving an essential role in RNA regulation. Our lab has shown that one of TDP- 43’s function is to repress
splicing of non-conserved cryptic exons to ensure formation of a normal transcriptome. When TDP-43 is depleted
from the nucleus, these cryptic exons get spliced into messenger RNAs. The inclusion of cryptic exons often
introduces frameshifts or premature stop codons in mRNAs, disrupting their translation.
To complement the loss of splicing repression by TDP-43, our lab has made a construct, termed CTR,
that replaces the prion-like C-terminal domain of TDP-43 with a well-characterized splicing repressor domain
derived from ribonucleoprotein, PTB-binding 1 (RAVER1). CTR has been shown to repress majority of cryptic
exons in mouse embryonic stem cells lacking TDP-43. Cryptic exons of TDP- 43 in mice are distinct from those
of primates even though TDP-43’s protein sequence is highly conserved among different organisms. These
cryptic exons are diverse and cell type-specific in nature. Our preliminary analyses show that human astrocytes
have a unique set of cryptic exons after TDP-43 loss that are not expressed in TDP-43 deficient neurons.
Moreover, in preliminary data, we have demonstrated that CTR can rescue the disease phenotypes observed in
TDP-43 deficient human ipsc-derived cortical i3 neurons (i3N). CTR can attenuate cell death, aid survival, and
decrease cryptic HDGFL2 protein in TDP-43 deficient i3 neurons.
The overarching goal of this proposal is that human cryptic exons are species and cell type specific
and CTR can repress cryptic exon incorporation and rescue synaptic physiology and cell death in TDP-
43 deficient human cortical neurons. I will test this hypothesis by knocking down TDP-43 using lentivirus
containing shRNA against TDP-43 in human cortical neurons, administering CTR by lentivirus transduction,
using RNA sequencing, performing immunohistochemical analysis, and conducting mini electrode assay
recording and whole-cell patch clamp. In Aim 1, I will determine whether there are cell-specific cryptic exons in
human neurons, astrocytes, and oligodendrocyte progenitor cells. In Aim 2, I will determine whether CTR can
prevent cryptic exon incorporation and restore normal synaptic function and rescue cell death in TDP-43 deficient
human iPSC-derived neurons.

Public health relevance
PROJECT NARRATIVE TDP-43 is a highly conserved nuclear RNA binding protein that serves a crucial role in RNA regulation and metabolism. The nuclear clearance of TDP-43 has been implicated in many neurodegenerative diseases, however very little is known about the loss of TDP-43 in glial cells despite playing a role in the progression of these diseases. This proposal explores how the loss of TDP-43 in glial cells alter their function and whether TDP-43 loss-of-function can be targeted therapeutically using a novel splicing repressor.